Clinical Trials Program

The overall goal of the proposal is to advance prevention interventions for HPV-associated cancers
occurring among men and women living with HIV in Latin America and the Caribbean (LAC). We are focusing
on prevention of two HPV-associated cancers, oropharyngeal cancer and cervical cancer. Both cancers are
significantly elevated among individuals living with HIV compared to HIV negative populations and present
prevention, screening, and treatment challenges requiring new solutions.
To address these significant public health concerns, we will perform the following clinical trials:
1. Investigate immunoprevention of persistent oral HPV infection, a surrogate for prevention of HPVassociated OPC, by conducting a double-blind, randomized, placebo-controlled trial of the 9-valent
HPV vaccine among men living with HIV in Brazil, Mexico and Puerto Rico
2. Evaluate and optimize primary HPV screening with triage to HPV/host DNA methylation for cervical
cancer screening among women living with HIV
3. Evaluate non-surgical approaches for treating HPV-related cervical pre-cancer by evaluating the
safety, immunogenicity and preliminary efficacy of a novel HPV therapeutic vaccine, PDS0101, in
women living with HIV diagnosed with cervical HSIL

Public health relevance
PROJECT NARRATIVE In this project, we propose the Multinational Partnership to Prevent HPV-Associated Cancer in People Living with HIV: Brazil, Mexico, Puerto Rico (PHAC-BMPR) that will bring together experienced research sites and world-renowned HPV and HIV researchers to build on established collaborations to conduct clinical trials on prevention of HPV-associated cancers among people living with HIV. This will provide an invaluable opportunity for newer investigators from Latin America/Caribbean (LAC) to participate in and learn from high- quality research. We are performing clinical trials that will help reduce the burden of two HPV-associated cancers in LAC: HPV-associated oropharyngeal cancer and cervical cancer.